Integrated super-resolution CMR-deep learning to deconvolute passive and active causes of impaired relaxation

SUMMARY
Left ventricular (LV) diastolic dysfunction (LVDD) is a key contributor to the pathophysiology of several cardiac
diseases, including diabetic cardiomyopathy, hypertrophic cardiomyopathy, and heart failure with preserved
ejection fraction. LVDD has two common sequelae: restrictive filling and impaired LV relaxation (ILVR). The
restrictive filling is caused by the passive stiffening of the LV, generally linked to fibrotic and hypertrophic events
in the LV free wall myocardium (LVFW). ILVR, on the other hand, is thought to be driven by alterations in cross-
bridge cycling kinetics impairing active force development and relaxation in the LVFW. However, the role of
passive myocardial alterations in ILVR remains unknown, while its understanding is central to the treatment of
ILVR as passive and active causes of ILVR demand different therapeutic choices. Moreover, the current
characterization of ILVR remains limited to echocardiography and hemodynamic indices, such as mitral annular
relaxation velocity and diastolic time constant. These indices quantify only the “net” manifestation of underlying
active and passive causes of ILVR at the organ level, falling short of suitable measures to distinguish cellular-
and fiber-level mechanisms, collectively, leading to ILVR. As such, a feasible technology that can segregate and
quantify contributions of passive and active causes of ILVR in vivo remains elusive, while it is essential for
simplifying the etiologic heterogeneity of LVDD.
Our central hypothesis is that passive and active remodeling events are independent, but competing,
contributors to ILVR, and integrated super-resolution cardiac magnetic resonance imaging-deep learning (CMR-
DL) can isolate and quantify the contribution of each event to LVDD in diseased and treated subjects in vivo. We
propose to test our hypotheses via three specific aims: 1. Determine contributions of passive and active
remodeling events to LVFW slow relaxation in mice ex vivo. We will identify and separate the contributions of
passive and active remodeling events to LVFW slow relaxation in diabetic murine models of LVDD and newly
generated knock-in mice models. 2. Predict passive and active contributions to ILVR using CMR-DL in mice in
vivo. We will use subject-specific inverse models integrated with DL to estimate the contributions of passive and
active causes of LV impaired relaxation in vivo. 3. Dissect LVFW passive and active contributions to ILVR using
common clinical metrics in humans. We will estimate the independent contributions of active and passive forces
to echocardiography indices of the ILVR in four phenotypes of retrospective LVDD patients. The completion of
these studies will: 1) determine passive fiber-level alterations in the LVFW that would be most deteriorating to
LV relaxation, and 2) advance individualized treatment of LVDD based on identified contributors to ILVR and
diastolic dysfunction through integrated CMR-DL.

Public health relevance
NARRATIVE Heart failure in the left ventricle occurs when the heart cannot provide sufficient blood flow to the body. About half of heart failures happen when the left ventricle cannot properly relax. Despite the common understanding that poor relaxation is caused by changes in active characteristics of the left ventricle, our findings suggest that changes in passive properties of the left ventricle tissue play a key role in poor relaxation. In this application, we propose to separate the contributions of passive and active changes to poor relaxation and determine if restoring passive properties improves the left ventricle relaxation.